Hippocampal and Genetic Mechanisms Underlying Development of Depression in Children at High Family Risk

PROJECT SUMMARY
Why do some children at high risk for depression develop a disorder, while others remain psychopathology-
free? My ultimate goal is to elucidate the neurobiological, genetic and environmental factors that determine
vulnerability or resilience in children at risk for mood disorders, so that children at highest risk can be identified
and new interventions against depression can be developed. This goal will be enabled by the training and
mentorship obtained through this K99/R00 Award. Preliminary results show that findings from rodent models
of intergenerational distress replicate in humans. Specifically, offspring of parents with depression and distress
have decreased hippocampal structure, cognitive difficulties and a higher risk for depressive symptoms. The
research in this proposal will examine if recent findings from these rodent models, that hippocampal activity
determines susceptibility versus resilience to adverse events, translate to humans at risk for psychopathology
in a multigenerational family study of individuals at high and low risk for depression. Next, I will investigate
whether measures of cumulative genetic risk predict individual differences in hippocampal structure and
function and depressive symptoms. I will investigate genome wide association studies-based polygenic risk
scores and also derive a translational expression-based genetic risk score that is specific to altered dentate
gyrus gene expression in susceptible versus resilient mice and apply it to humans. Lastly, to determine
whether hippocampal measures predict onset of depression, investigate interactions with the childhood
environment, as well as extend findings to a large diverse population sample, I will examine these questions in
children from the Adolescent Brain and Cognitive Development Study. To carry out this research I will receive
training during the K99 phase at Columbia University/New York State Psychiatric Institute from an
interdisciplinary team of mentors and advisors. My training will include: resting-state fMRI analysis; using
pipelines to analyze large samples of MRI data; calculating and incorporating polygenic risk scores into
neuroimaging and clinical datasets; and professional skills. The data obtained in this project will lead to future
R01 applications during the R00 phase that will determine when in childhood aberrant hippocampal
mechanisms emerge, examine the effects of altered hippocampal processing on connected brain regions and
use the genetic findings to develop a theory of the molecular changes underlying aberrant hippocampal
function. This project will elucidate biological mechanisms of susceptibility to depression in high-risk children
and give me the expertise to become a leader in integrating genetic, neural and environmental data across
species to study intergenerational transmission of psychopathology.

Public health relevance
PROJECT NARRATIVE The offspring of parents with major depression have a very high risk of developing mood disorders and other psychopathology themselves. The neurobiological and genetic mechanisms that lead to their vulnerability or resilience remain unclear. Leveraging a unique translational approach with hypotheses generated from rodent studies applied to highly characterized clinical studies and then extended to large diverse population samples, this proposal will investigate hippocampal, genetic and childhood environmental factors that predict onset of depression in children at high risk for mood disorders.